Scientific training in addiction research techniques (START) for gifted future investigators from historically underrepresented and underserved backgrounds

PROJECT SUMMARY This administrative supplement proposal aims to incorporate training in the collection and analysis of Adolescent Brain Cognitive Development (ABCD) data for under-represented scholars. The program, titled “Scientific Training in Addiction Research Techniques (START) for gifted future investigators from historically underrepresented and underserved backgrounds,” aims to increase access to this rich dataset by providing hands-on instruction and mentorship. Recruitment of twelve trainees (four postgraduate students, four postdoctoral trainees, and four early career faculty) will be led by Dr. Johnson of the University of South Florida, availing of his years of experienced recruitment activities working with diversity, equity, and inclusion groups including the McKnight Doctoral Fellowship Program (statewide, Florida), South Regional Education Board (16 US states), Edward A. Bouchet Graduate Honor Society (18 universities), Black Doctoral Network (International), and Historically Black Colleges and Universities (nationwide). Training will be provided at the University of Vermont led by Drs Garavan and Potter, an ABCD data collection site with very strong connections to the ABCD data and administrative centers. Training will include exposure to the multi-modal data collection methods utilized in ABCD, instruction on the breadth and depth of the ABCD assessments and measures, guidance on the methods for accessing and analyzing these data, and mentorship for the conduction of a year-long research project. Support will be provided throughout the year and will include active inclusion of the trainees into the nationwide ABCD team providing valuable networking and educational opportunities. The training will culminate in an end-of-year symposium at the University of South Florida during which the results of the projects will be disseminated and the efficacy of strategies for training and retaining underrepresented minority researchers will be evaluated. There is a detailed plan of supervision and progress monitoring for the full year with quantitative assessments of program success. This program is a valuable contribution to developing a functionally diverse team of investigators who will enrich the insights to be gained from this unique dataset on adolescent health and development.

Public health relevance
PROJECT NARRATIVE This project aims to enhance diversity, equity, and inclusion among the next generation of substance misuse scientists by implementing a comprehensive research education program for doctoral candidates, postdoctoral researchers, and early-stage investigators who are underrepresented minorities or from disadvantaged backgrounds. The program will provide training and mentorship for research projects utilizing data of the Adolescent Brain Cognitive Development study and is a collaboration between the University of Vermont and the University of South Florida.